Microbiome Based Biomarkers of Wound Healing

Abstract
Diabetic foot ulcers (DFU) impact over 2 million Americans annually, result in over 130,000 amputations each
year, and are associated with high mortality rates. To date, there has been no single infectious agent of DFU
identified as a good marker of healing outcome. This is likely because DFUs are host to a diverse community of
microbes (i.e., the wound microbiome). Wound microbiomes analyzed at the community-level are promising
predictors of wound healing outcomes. We have shown that wounds persisting beyond 12 weeks exhibit high
and persistent proportions of mixed-population, anaerobic bacteria within their microbiomes. Additionally, we
found a significant increase of anaerobic transcriptional activity in persistent and amputated wounds, even from
species identified as being in low abundance by traditional 16S rRNA based gene sequencing. This suggests
microbial transcription, and specifically from anaerobic bacteria, are promising biomarkers of wound healing in
diabetic patients.
The proposed project will identify microbial biomarkers that can be used as prognostic and monitoring tools for
DFU wound healing. We hypothesize using RNA instead of DNA will provide a better snapshot of the wound
environment and more sensitive biomarkers: specifically, the proportion and transcriptional activity of anaerobes
within the wound microbiome can be used as predictors of wound healing outcomes. Using RNAseq to measure
the metatranscriptome of the DFU microbiome, we will leverage advances in machine learning approaches to
demonstrate the capacity of the anaerobic component of the wound microbiome to serve as a biomarker for
wound healing. We have vigorously evaluated the optimal sample collection techniques and methods of
detection, determining a simple swab of the ulcer bed is sufficient to characterize the metatranscriptome and will
facilitate clinical implementation. We will develop a multiplexed RT-qPCR assay for the panel of candidate
biomarker genes we identify and validate the assay sensitivity, specificity, accuracy and precision. We will work
closely with the Diabetic Foot Consortium Steering Committee and Data Coordinating Center to test and validate
our biomarkers in a multi-site trial with the DFC. Our goal is to develop a multiplexed biomarker assay integrating
the complex interactions occurring within the DFU microbiome and tissue microenvironment. It will use a simple
swab of the ulcer bed, rely on objective measurements, and is designed to predict healing trajectories at an early
time in the clinical course.

Public health relevance
Project Narrative/Public Health Statement Diabetic foot ulcers are a major complication of diabetes leading to an increased risk of lower extremity amputation and death. A major hurdle to the development of new therapies for diabetic foot ulcers is the lack of biomarkers to predict healing and response to treatment. The proposed work will developed a multi-panel biomarker assay based on the wound microbiome to predict healing outcomes.